Assessing Markey Cancer Center's Alignment with National Standards for Survivorship Care

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-
CA-24-032. This administrative supplement application pertains to the National Cancer Institute (NCI) P30
Cancer Center Support Grant that supports the Markey Cancer Center (MCC), a university-based matrix cancer
center at the University of Kentucky (UK). The mission of MCC is to reduce cancer burden through research,
prevention, treatment, education and community engagement, with a focus on Kentucky and its most vulnerable
populations. As the only NCI-designated Comprehensive Cancer Center in the state, MCC is vital to Kentucky,
the state which leads the nation in all-site cancer incidence and mortality. MCC aims to translate scientific
discoveries into innovative and personalized diagnostic and treatment advances that improve the lives of cancer
survivors. Consistent with MCC’s goal to provide exceptional patient-centered, outcome-driven cancer care that
exceeds expectations of cancer survivors and caregivers alike, MCC employs advanced practice providers who
deliver survivorship care. NOT-CA-24-032 provides a perfect opportunity to examine the quality of MCC
survivorship care and take initial steps toward improvement and expansion. The specific aims of the
administrative supplement are: 1) Describe the degree to which MCC survivorship care meets the National
Standards for Survivorship Care; 2) Identify MCC cancer survivor and caregiver-reported barriers and facilitators
to accessing MCC survivorship care and explore differences based on survivors’ treatment phase, disease stage,
and geographic residence; and 3) Ascertain promising implementation strategies to improve the quality, reach,
adoption, and effectiveness of MCC survivorship care. To accomplish these specific aims, a concurrent mixed-
methods study that is guided by the Practical Robust Implementation and Sustainability Model and includes
multiple stakeholders (specifically, MCC providers, administrators, advisory group members, survivors and
caregivers) as participants will be conducted during the 1-year award period. With unique research strengths
and a firm commitment to quality cancer care, MCC is well-poised to generate robust data that will improve the
survivorship care it provides.

Public health relevance
PROJECT NARRATIVE Markey Cancer Center is the only NCI-designated Comprehensive Cancer Center in the state of Kentucky, and its catchment area includes all 120 counties in Kentucky. The mission of Markey Cancer Center is to reduce cancer burden, which necessitates translating scientific discoveries into innovative, personalized care and providing the highest quality care to cancer survivors. This administrative supplement aims to assess alignment between survivorship care at Markey Cancer Center and the National Standards for Cancer Survivorship Care, identify determinants of survivorship care access for survivors and their caregivers, and identify implementation strategies to improve quality, effectiveness, adoption, and reach of survivorship care at Markey.